Development of a Novel mHealth Platform to Track Health Behaviors of Young Children with Down Syndrome

Project Summary/Abstract
Approximately half of all children with Down syndrome are obese, placing them at disproportionately high risk
of diabetes mellitus, obstructive sleep apnea syndrome, and gait disorders. Despite these risks, prevention
efforts have been neglected in this population. The research proposed in this application seeks to develop a
novel mHealth platform to track the health behaviors of young children with Down syndrome and identify
behaviors that may contribute to rapid weight gain during early childhood. The innovative Early Child Health:
Down syndrome (EACH DS) platform will prompt caregivers to track health behaviors linked to weight
outcomes and provide this data securely to clinicians. EACH DS seeks to shift clinical practice paradigms by 1)
highlighting the importance of identifying Down syndrome specific risk factors for rapid weight gain early in life,
2) informing clinical treatment plans related to health promotion, and 3) providing a platform to assess health
behaviors and build just-in-time interventions to support family-centered behavior change. This work
represents a necessary shift in the focus of early care to prevent obesity and reduce weight-related health
disparities observed among children with Down syndrome. To design a stakeholder-relevant mHealth platform,
we will follow the agile software development model, emphasizing iterative feedback from end-users of the
technology. We will engage both caregiver and clinician (i.e., occupational, physical, and speech-language
therapists) end-users to promote future implementation and adoption of the EACH DS mHealth platform. We
will collect qualitative and quantitative data to gather feedback on EACH DS's flow, functionality, and usability
while designing, developing, and pilot testing this novel technology. We will first design EACH DS using
iterative focus group discussions with caregivers (n~24) and clinicians (n~24; aim 1a). Next, we will develop a
fully functional version of EACH DS and establish content validity as informed by an expert panel (n~6; aim
1b). Then, we will pilot test and optimize the EACH DS platform with caregivers (n=10) and clinicians (n=10)
over 30 days (aim 2). Usage data (e.g., response rate, frequency of use) and data on child health behaviors
will be collected directly from the EACH DS mobile application and clinician portal. Participants will complete
surveys and brief interviews to describe and rate the clinical utility, acceptability, and overall usability of EACH
DS. Benchmarks have been established to determine the usability and acceptability of EACH DS. The
research team demonstrates requisite expertise in mHealth development, ecological momentary assessment,
Down syndrome, and health promotion to complete the study. The long-term goal of this line of research is to
prevent obesity among children with Down syndrome. This project is directly aligned with the Notice of Special
Interest for mHealth technology to support the assessment and intervention to promote health for individuals
with Down syndrome (NOT-OD-21-092).

Public health relevance
Project Narrative Approximately half of all children with Down syndrome are obese, yet obesity prevention efforts have been neglected. This study will deliver a stakeholder-informed, novel mHealth platform, Early Child Health: Down syndrome (EACH DS), to track health behaviors and identify young children at risk for rapid weight gain. Knowledge generated from this research will inform the optimization and wide-scale implantation of this technology and support the development of just-in-time health-promoting interventions for young children with Down syndrome.